Characterizing High Frequency Oscillations as an epilepsy biomarker with Big Data tools

PROJECT SUMMARY
Epilepsy is one of the world’s most prevalent diseases, yet the rate of uncontrolled seizures has not
changed in decades. One of the reasons for this is our limited understanding of seizure mechanisms, and so
one of the main goals of epilepsy research is to identify new biomarkers to help us understand the nature of the
disease. Recent technological advancements now allow us to monitor brain activity with much higher
resolution, which have led to the identification of promising potential biomarkers such as High Frequency
Oscillations (HFOs). Unfortunately, clinicians still have not determined how to utilize this information under
clinical conditions. There are three main obstacles to implementing HFOs in practice: 1) they are difficult to
find; 2) it is unclear how to ascertain which HFOs are truly related to epilepsy; and 3) it is unclear how to use
the HFO data in a prospective fashion to improve clinical care. The purpose of this project is overcome each of
these obstacles. In the past funding period, we developed and validated an HFO detection algorithm that
overcomes the first obstacle, and allowed us acquire a massive database of HFOs that have opened new
avenues of research. In this proposal, we will leverage that algorithm to move HFOs towards clinical
translation. In the first Aim, we apply advanced functional connectivity techniques to quantify the network
properties of HFOs. Our data, which comprise HFOs from the entire hospitalization and fully curated
metadata, are ideal for robust analyses of this new area of HFO research. The second Aim addresses a
longstanding, and still unsolved problem in HFO research: how to discern when HFOs are due to epileptic
processes versus normal physiology? Our past funding period identified some potential methods to identify
pathological HFOs, but also crucial caveats that must be addressed prior to clinical implementation. This Aim
will combine multiple classification methods with state-of-the-art machine learning tools to distinguish
epileptic from normal HFOs. It will also conduct a large human expert classification of HFOs using clinical
EEG software, to start involving epilepsy clinicians in the direct evaluation of HFOs. The third Aim will further
develop the translational potential of HFOs, incorporating our unique longitudinal clinical data to characterize
the effects of medications, sleep, and other time-varying effects on HFO rates. It will then incorporate these
and all prior HFO data into a rigorous latent class model to predict how likely each channel is to be epileptic.
These Aims together serve as the framework to establish HFOs as a clinically viable biomarker of seizures,
allowing their translation into clinical epilepsy care and leading to future prospective clinical studies using
HFOs to guide prospective clinical decisions.

Public health relevance
PROJECT NARRATIVE The goal of this project is to characterize a novel biomarker of seizures using advanced computer algorithms that monitor brainwaves in real time. These biomarkers, known as High Frequency Oscillations, have been recognized for some time but their research has been restricted to very short datasets within a handful of centers worldwide. This project will use Big Data tools to help translate these biomarkers into widespread use while exploring several novel ways in which they will help clinicians identify seizures.